Porcine Related apprOach to Multidisciplinary cOllaborative Translational ModEl Research (PROMOTER)

Porcine Related Approach to Multidisciplinary Collaborative Translational Model Research
(PROMOTER)
ABSTRACT
Large animal models of human disease are essential to the development, testing, and translation of
therapeutics, but fully characterized large animal models of digestive diseases are relatively lacking. Within this
broad digestive disease category, esophageal diseases are an attractive use case, being increasingly
prevalent but paradoxically understudied. There are no approved esophageal-specific drugs or delivery
mechanisms, and fundamental questions remain about disease pathogenesis, natural history, outcomes, and
individualization of care. There is a critical need for a large animal model “toolbox” for discovery work enabling
rapid translation of knowledge to practice for esophageal diseases. Because small animal models do not
recapitulate human esophageal micro- or macro-structures, are minute in size, and require sacrifice to obtain
tissue for examination, progress in many areas of research is hampered. In contrast, the pig is an ideal
esophageal model. The pig esophagus is analogous in structure and function to the human esophagus, with
similar epithelial and sub-epithelial compartments, and motility. In addition, as the pig and human esophagus
are of similar size, the pig model is amenable to endoscopic assessment, enabling both visual inspection and
recovery of tissue samples without sacrificing the animal. This facilitates critical long-term modeling to study
disease pathogenesis, progression, and outcomes that are of direct clinical interest. We have begun to
establish the viability of the porcine esophageal approach as a novel resource by exploring injury/repair, the
role of stem cells, and drug delivery (with both novel mucosal-targeted formulations and drug-eluting devices),
and have created a porcine disease model for eosinophilic esophagitis which demonstrates clear translational
potential to human disease. With our established multidisciplinary team, we propose to use the RC2
mechanism to accelerate discovery and translation to the clinic in esophageal diseases and ultimately in other
organs. Our application has been designed to meet all objectives of the High Impact Specialized Innovation
Program, as well as multiple CTSA program goals, with the following specific aims: 1) To generate a
comprehensive transcriptional, immunologic, and proteomic profile of the normal porcine esophagus; 2) To
develop and generate comprehensive transcriptional, immunologic, and proteomic profiles of porcine models of
inflammatory/injury-induced and fibrotic esophageal diseases; and 3) To establish an integrated and self-
sustaining center that shares resources with the scientific community to promote translational multidisciplinary
research, fundamental hypothesis testing, and therapeutic drug and device development in esophageal
diseases, as an initial platform for extension to other human diseases. This highly innovative and impactful
discovery-based and hypothesis-generating research will overcome roadblocks in translational science and
enhance activities of the UNC/NC State CTSA UM1 Hub, successfully address a major impediment to
translational science, and advance translation of drugs and devices to the clinic.

Public health relevance
NARRATIVE Large animal models of human disease are essential to translate therapeutics to humans, but there is a relative lack of fully characterized large animal models of digestive diseases, and esophageal diseases in particular, and a critical need for a toolbox for discovery work to allow rapid translation of knowledge to practice. The goals of this proposal are to generate a comprehensive transcriptional, immunologic, and proteomic profile of the normal porcine esophagus, develop and generate comprehensive transcriptional, immunologic, and proteomic profiles of porcine models of inflammatory/injury-induced and fibrotic esophageal diseases, and establish an integrated and durable center that shares resources with the scientific community to promote translational multidisciplinary research, fundamental hypothesis testing, and therapeutic drug and device development in esophageal diseases, as an initial platform for subsequent extension to other GI and human diseases. This multidisciplinary work, conducted by researchers at the University of North Carolina School of Medicine and the North Carolina State College of Veterinary Medicine, meets the objectives of the High Impact Specialized Innovation Programs, will enhance the activities of the UNC/NC State CTSA UM1 Hub, and will address a major impediment to translational science.